Protist Oxygen Sensing in Human Disease Protist Oxygen Sensing in Human Disease

Sensing and responding to changes in environmental oxygen is critical for
aerobic organisms. Metazoans accomplish this by destabilizing a transcription
factor called hypoxia inducible factor (HIF) in oxygen sufficiency. This is achieved
by an oxygen-dependent prolyl 4-hydroxylase (PHD) that hydroxylates proline
residues in the HIF-1α transcription factor that targets it for ubiquitin-dependent
proteasomal degradation. Protozoans have PHDs but lack HIF and thus respond
to changes in oxygen differently and we use the evolutionary distant protists
Dictyostelium and Toxoplasma to address this question. Initial studies in
Dictyostelium revealed that its PHD, DdPHYa, modifies a proline in Skp1, which
is a component of the Skp1/Cullin1/F-box protein/Rbx1 polyubiquitin ligase
complex. Skp1 prolyl hydroxylation does not affect its stability, but allows it to be
modified by a pentasaccharide that acts to alter the repertoire of associated F-
Box proteins. Genome analysis and biochemical assays demonstrated that this
Skp1 modification pathway is conserved in the protozoan parasite Toxoplasma,
but not in metazoans. Loss of Toxoplasma PHYa leads decreases virulence in
vivo and decreased growth in vitro under limited O2 and amino acid conditions.
Unlike Dictyostelium, Toxoplasma expresses a second PHD, PHYb, which is
required for colonization of oxygen rich tissues as well as Toxoplasma growth at
high oxygen. In contrast to PHYa, PHYb functions by regulating elongation
during protein synthesis and specifically does so at elevated O2 levels. Because
of its medical importance, we will focus on Toxoplasma and pursue three specific
aims: i) Determine how PHYa mediates growth at low oxygen and amino acids;
ii) Define how PHYb regulates elongation; and iii) Test whether PHYa and PHYb
work in tandem as an oxygen-sensing rheostat to grow in whatever oxygen
tension in encounters as it infects a host and causes disease.

Public health relevance
The protozoan parasite Toxoplasma gondii latently infects 11-22% of Americans and can cause disease in immunocompromised patients and fetuses. As the parasite traffics through the body where it encounters diverse environment that it must adapt to or will die. The work proposed here is focused on learning how the parasite adapts to these environments with the ultimate goal of developing new therapies and treatments.